THE MAINTENANCE OF CLOSE DYADIC RELATIONSHIPS

The major focus of the proposed work will be the study of the role of emotional expression, control and responsiveness in close dyadic relationships. This role will be studied using a longitudinal, multimethod assessment of emotion during social interaction; data include observational, questionnaire, interview, psychophysiological, and video recall. Three kinds of relationships will be investigated - marriages, children's friendships and childrens acquaintanceships. The work on children's emotional development involves the research development, which continues in the areas of emotion and psychophysiology.